Influence of hypoxia on the antiviral functions of human intestinal epithelial cells

Project Summary
Enteric viruses infect or initiate their lifecycle through the gastro-intestinal tract. Pathogenic enteric viruses
(e.g. rotavirus, norovirus) are of major clinical importance as they cause a great fraction of pediatric diarrheal
cases globally and can lead to life threatening infection in immune compromised patients. The intestinal
epithelial cells constitute the primary barrier that enteric viruses need to face to initiate infection. They are
organized in discrete crypt-villus structures with the stem cells located in the crypt region and the
most differentiated cells (e.g. enterocytes) at the tip of the villi. Along the crypt/villus structure a steep oxygen
gradient exists placing the crypts under “normal” oxygen level (normoxia) and the tips of the villi under very
low oxygen levels (hypoxia). While hypoxia is well known to be critical for a healthy commensal microbiota
and for regulating inflammation during inflammatory bowel disease flare-ups, how hypoxia impacts
infection of intestinal epithelial cells by enteric viruses remains unknown. In this application, we will
employ a set of human enteric viruses, human intestinal organoids, and gut-on-a-chip technologies to fill this
gap of knowledge. In preparation for this research proposal, we have discovered that hypoxia negatively
impacts the intrinsic innate immune response generated by primary non-transformed human intestinal
epithelial cells upon viral infection. We have shown that hypoxia impairs interferon production, as such
favoring enteric virus replication. Using an organ-on-a-chip, we reproduced the oxygen gradient present in
the crypt/villus structures, and have shown that hypoxic regions, representing the villus tips, are more
susceptible to viral infection due to a curtailed immune response in intestinal epithelial cells. Additionally, we
have gathered evidence that stem cells and differentiated cells (e.g. enterocytes) differently respond to
hypoxia. As such we hypothesize that the gut hypoxic milieu generates a proviral environment in
intestinal epithelial cells by dampening the innate immune response, thereby favoring enteric virus
infection, replication, and spread. To challenge these hypotheses, we will first build on our preliminary data and
refine our molecular understanding of the hypoxia-mediated inhibition of immune response. Second, we will
define how the physiological oxygen gradient creates distinct microenvironments within the crypt/
villus axis with the hypothesis that these microenvironments have distinct capacities to control viral
infection. Finally, we will characterize at the single cell level how hypoxia induces cell type-specific
inhibition of immune response (stem cells vs enterocytes) and spatially integrate these findings into the
crypt/villi structure using organ-on-a-chip technologies. Our findings will inform the development of
novel therapeutics targeting cellular responses to hypoxia not only to treat enteric viruses, but also
other enteric pathogens, as well as for the treatment of inflammatory bowel diseases which is
accompanied by oxygen-dysregulation in the gut.

Public health relevance
Narrative The low oxygen environment (hypoxia) in the gastro-intestinal tract is fundamental for the preservation of the commensal microbiota and the maintenance of gut homeostasis. How hypoxia impacts the ability of intestinal epithelial cells to respond to enteric viruses is unknown and this constitutes the core question of this project. Manipulation of the cellular response to hypoxia could constitute a novel pharmacological approach to combat enteric viruses.